2022 Cornea and Ocular Surface Biology, Pathology and Regeneration GRC/GRS

Project Summary
The ocular surface is comprised of the cornea, conjunctiva, eyelids and associated glands that are responsible
for secretion of the tear film. Dysgenesis or disruption of the homeostasis of any of these structures can lead to
corneal and ocular surface diseases, which can result in loss of eyesight or cause blindness. Understanding the
genesis of the ocular surface tissues, and its normal function and repair after disease or trauma, is crucial for
identifying disease-associated genes and novel drugs that may lead to innovative therapies that are essential
for maintaining visual health. We request support for the Gordon Research Conference and Seminar of the
Cornea and Ocular Surface Biology, Pathology and Regeneration (GRC-COSBPR), February 13-18, 2022, at
Ventura Beach Marriott in California. The goal of the 2022 GRC-COSBPR is to bring together international
leaders in the field and provide a forum for the most recent, cutting-edge basic, translational and clinical research
focused on expediting translation of findings from bench to bedside. Building on the strong track record from the
past six meetings, we plan 9 scientific sessions on key paradigm shifting innovations in ocular surface biology,
pathology, and tissue repair. The session titles are: 1. Novel Approaches to Data Acquisition and Analysis; 2.
Cellular Interactions, the Extracellular Matrix, and Morphogenesis; 3. Genomics and Gene Regulation; 4.
Advances in Cornea and Ocular Surface Wound Repair; 5. Mechanisms of Ocular Surface Disease and
Disorders; 6. Stem cells of the Ocular Surface; 7. Inflammation and Regeneration of the Ocular Surface; 8.
Sickness and Health of the Cornea and Ocular Surface; 9. Translation of Ocular Surface Research into Novel
Therapies. We are organizing a diverse, gender-balanced meeting with speakers invited from North and Latin
America, United Kingdom, Israel, Asia (Japan, India, China), and Australia. Special emphasis will be given to
increase diversity by inviting women and underrepresented minorities. Each session will be co-moderated by an
early career scientist paired with an established researcher. The sessions will include extended time for
discussions. A portion of each session is uncommitted to select speakers from submitted abstracts, particularly
early career investigators. The GRC conference will include a “Power Hour” to discuss challenges women and
underrepresented minorities face in science and issues of diversity and inclusion. The 2022 GRC will be
preceded by the 5th two-day Gordon Research Seminar (GRS) led by dedicated students and post-docs. The
GRS provides an opportunity for young scientists to present their research in a non-intimidating environment,
with support and feedback from a few senior scientists. The GRS start of the meeting fosters community building
and long term relationships. The 2022 GRC-COSBPR meeting will be advertised by the GRC and the program
updates will be posted on the website and via social media such as Twitter and Facebook to increase visibility
among junior scientists and trainees. We believe our program is aligned with the scientific goals of NEI and its
support will enable us to provide a high quality and successful meeting.

Public health relevance
Project Narrative The proposal requests funds to support a meeting that brings together international leaders and early career investigators in cornea and ocular surface research. The meeting will provide a forum for the most cutting-edge basic, translational and clinical research aimed at developing novel therapies to prevent or treat corneal blindness.